FASEB SRC on Liver Biology: Fundamental Mechanisms & Translational Application

DESCRIPTION (provided by applicant): The current application seeks partial support for the Federation of American Societies for Experimental Biology (FASEB) summer research conference on Liver Biology: Fundamental Mechanisms & Translational Applications. For the past 20 years, this meeting has been held biennially and is now recognized as the world's premier conference covering all aspects of basic science research involving the liver. The conference will be held from July 29-August 3, 2012 in Snowmass, Colorado. The main goals of the conference are to i) integrate the research advances offered by disparate areas of liver biology in order to foster new collaborative projects on both national and international scale, ii) encourage junior and early stage investigators, women and minority scientists to pursue liver research to ensure that the study of hepatic disease and biology remains vigorous and iii) accelerate translation of fundamental advances in liver biology into novel clinical treatments through the interactions of basic and clinical researchers. These goals will be achieved through specific programmatic strategies. The program is divided into nine major sessions and includes presentations from thirty-nine invited speakers. In addition, these sessions will accommodate multiple short 'late-breaking' talks that will be chosen to represent the most significant and timey research advances in liver research. Preference will be given to junior, minority and women investigators. The program also provides two poster sessions for one-on-one dialogue and several additional opportunities for informal, yet intimate scientific exchange among speakers and attendees throughout the stay and a newly added meet-the-experts session that will be geared towards and will allow younger investigators an additional opportunity to network with the more established and senior investigators in the liver field. Specific session topics include liver differentiation and organogenesis, Regulation of hepatobiliary gene expression in health and disease, Liver growth and regeneration, Liver metabolism in health and disease, Angiogenesis, Injury and Hepatic fibrosis, Liver cancer, Liver stem cells: Implications in regenerative medicine and development and Hepatocyte, stem cell transplantation and tissue engineering. This conference advances the goals of the NIH action plan for liver disease research in a format that truly integrates multiple disciplines, clearly emphasizing the novelty and significance of the FASEB summer research conference. Thus, the program incorporates the most relevant and timely topics in basic and applied aspects of liver health and disease to promote scientific exchange, dissemination, education and collaboration and translation. PUBLIC HEALTH RELEVANCE: The FASEB summer research conference on Liver Biology: Fundamental Mechanisms & Translational Applications is the premier international conference on basic and translational research in liver biology. The goal of the conference is to broaden the attendees' understanding of liver biology in order to advance treatment and diagnosis of liver diseases.

Public health relevance
The FASEB summer research conference on "Liver Biology: Fundamental Mechanisms & Translational Applications" is the premier international conference on basic and translational research in liver biology. The goal of the conference is to broaden the attendees' understanding of liver biology in order to advance treatment and diagnosis of liver diseases.